Interdisciplinary Research Network on Biologically Active Tau Aggregate Polymorphs from Alzheimer's Disease and Related Dementias

PROJECT SUMMARY
Tau aggregation is a shared pathology of Alzheimer's disease and related dementias known as tauopathies.
Because each disorder develops a unique combination of aggregate polymorphisms and co-morbidities that may
influence the course and severity of disease, elucidating the relationship between tau aggregate structure and
biological activity has become a high priority in the field. Advances to date have been limited, however, by the
lack of rigorously standardized aggregate preparations from each form of tauopathy and by the absence of tools
needed to selectively detect their presence in biological models and clinical specimens. The proposed
Interdisciplinary Research Network on Biologically Active Tau Aggregate Polymorphs seeks to address this need
by (1) isolating a full range of biologically active tau aggregates from authentic Alzheimer's disease, Corticobasal
Degeneration, Progressive Supranuclear Palsy, and Pick's disease brain tissue, (2) establishing their structures
through biophysical analysis, (3) developing probe sets for their selective detection, and (4) disseminating
reliably vetted samples and lab-ready protocols for their handling and storage to the broader research
community. In accomplishing these goals, the network will support research into the molecular basis of tauopathy
pathogenesis and catalyze efforts toward creating novel diagnostic and therapeutic strategies specifically tailored
against toxic tau aggregate polymorphs.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease and related dementias are characterized by the intracellular aggregation of tau protein. The goals of this project are to isolate and fully characterize tau aggregates from these diseases, and to provide them along with detection agents freely to the scientific community. The availability of well-vetted resources will catalyze research into how these diseases progress, how they may be diagnosed at early stages, and how they may be efficaciously treated.